Canonical and non-canonical roles of Argonaute proteins in mammals

Gene regulation by Argonaute (AGO) proteins is essential in mammals and has been implicated in a variety of human diseases including developmental disorders and cancer. Yet, a persistent challenge in the field is understanding how these proteins influence cell behavior and ultimately affect animal physiology and health. We are leveraging our expertise in mouse genetics in combination with computational, biochemical, and genomic approaches to gain a comprehensive understanding of the regulatory functions of these proteins in vivo, with an emphasis on the physiological roles of AGO-mediated RNA cleavage in mammals and the physiological functions of individual miRNA targeting events.